Interactions Between Genetics, Air Pollution, and Preschool-Onset Childhood Asthma

PROJECT SUMMARY/ABSTRACT
Asthma is the most common chronic disease among children in the United States and is influenced by both
genetic and environmental factors. Compared with White children, self-identified Black and Caribbean Hispanic
children are up to three times more likely to develop childhood asthma before the age of four years
(“preschool-onset asthma”). Preschool-onset asthma is associated with the highest hospitalization risk,
reduced lung growth, and lower lung function. There is a critical unmet need to identify the root causes of
preschool-onset asthma in minoritized children. A recent study from the CREW/ECHO consortium found that
PM2.5 and NO2 averaged over the first three years of life is associated with increased odds of early-onset
childhood asthma, and this association is increased among Black children. Furthermore, Black and Latinx
children are exposed to more pollution from every type of emission source in the US. It is unknown how
increased exposure to air pollution interacts with individual genetic risk factors to promote the development of
preschool-onset asthma.
This career development proposal is designed to evaluate gene-by-air pollution interactions to identify one of
the root causes for increased preschool asthma incidence rates among children experiencing environmental
injustice due to systemic racism. For this application, I propose the following specific aims: Aim 1: To conduct
a candidate gene association study for preschool-onset asthma. Aim 2: To identify single nucleotide
polymorphisms (SNPs) of preschool-onset asthma genes that interact with air pollution exposure in early life to
increase asthma risk. Aim 3: To identify associations between air pollution exposure in the first year of life and
the expression of preschool-onset asthma genes in nasal epithelial cells.
This NIH K08 proposal is supported by an expert team of transdisciplinary mentors and collaborator with
collective expertise in childhood asthma risk factors, environmental epidemiology, statistical genomics, and
transcriptomics analysis. This K08 award will allow the achievement of the following training objectives: (1)
Develop foundational training in genomic analyses and gene-environment interactions. (2) Increase expertise
in assessing air pollution as an environmental risk (3) Obtain skills in transcriptomics analyses to investigate
the association between the environment and the expression of preschool-onset asthma-related genes (4)
Cultivate the professional skills to become a national and international leader in childhood asthma disparities
research.
The findings of this proposal will provide novel insights into the molecular mechanisms of individual-level
susceptibility to air pollution among children in neighborhoods with high pollution exposure and will inform
personalized asthma prevention studies among children living in high-risk environments.

Public health relevance
PROJECT NARRATIVE Asthma is one of the most common chronic diseases in childhood and disproportionately impacts preschool-aged Black and Caribbean Hispanic children. This proposal will identify genetic variants related to preschool-onset asthma and evaluate gene-by-air pollution interactions contributing to disparities in preschool-onset asthma. These findings will inform precise molecular targets for the development of personalized prevention strategies among vulnerable children in under-resourced communities who are at risk for developing preschool- onset asthma.